Brown adipose NADH oxidase for thermogenesis

Obesity has become a global epidemic and is associated with type 2 diabetes and other chronic diseases. While WAT is the primary energy storage organ, brown adipose tissue (BAT) dissipates energy through non-shivering thermogenesis to maintain body temperature. Recently, a new brown fat specific cold inducible protein that has a NADH oxidase domain has been identified in the lab. While this NADH oxidase is lipid droplet associated, it localizes at the mitochondria during thermogenesis. The hypothesis of this research is that, through NADH oxidation, this enzyme uniquely functions in brown fat to regenerate NAD from NADH for optimal glycolysis in cytosol, while transferring electrons to mitochondrial electron transport chain, during thermogenesis. Initial examinations of NADH oxidase knockout mice that recently have generated show impaired thermogenesis with increased adiposity. In addition, transgenic mice overexpressing this NADH oxidase protein in brown adipocytes have been generated that showed enhanced thermogenesis. With these loss- and gain-of function mouse models in hand, the role and the underlying mechanism for this NADH oxidase in cold induced thermogenesis will be investigated.

Public health relevance
Obesity is a major health problem associated with metabolic syndrome and type 2 diabetes and the control of adiposity is a top priority in managing these diseases. Promoting thermogenesis may not only help in combating obesity but also in improving glucose/insulin homeostasis. This research is to understand a novel protein which is highly expressed only in brown adipose tissue functions for optimal thermogenic activity and thus may provide new therapeutic targets for obesity/diabetes.